OCTRI - Culturally sensitive model to improve cervical cancer screening uptake in Spanish-speaking and American Indian/Alaska Native communities

Overall - Project Summary
The Oregon Clinical and Translational Research Institute (OCTRI) is a mature CTSA hub that has been
accelerating research at Oregon Health & Science University (OHSU) since 2006. It has a stable, yet nimble,
leadership structure that has functioned efficiently during the current funding cycle to meet its goals. OCTRI
benefits from the guidance of several advisory groups in evaluation and planning and will use their input to
continuously improve its structure. OCTRI’s many effective programs assist investigators and trainees by
providing support services and fostering novel approaches to improve health in Oregon and beyond. OCTRI
will now build on these strengths, while broadening its reach, to address goals that align with the national
priorities articulated by NCATS and solidify its role within the CTSA network. OCTRI has developed nationally
recognized programs to build the translational workforce, and will strengthen this base to bring more diversity,
while also ensuring rigorous competencies are met. OCTRI has developed a regional reputation for leading
innovation and have incorporated these assets in an optional function with the Knight Cancer Institute that
supports the development of new therapeutics. OCTRI has built trust and capacity in research throughout rural
Oregon and will now extend these efforts to the Portland metropolitan region. OCTRI’s current optional function
has amplified the patient voice in research, and it will now be integrated into the community program in order to
extend its reach. OCTRI has led in the development of national informatics platforms and will now leverage
those to build internal support processes throughout OHSU to democratize these resources. At the same time,
OCTRI has recognized limitations with regard to data sharing and will develop a novel optional function to
incorporate Fast Healthcare Interoperability Resources to translate social determinants of health across
electronic systems. OCTRI has been at the forefront of innovative outcome evaluation and will fully implement
the Translational Science Benefits Model. These goals will be accomplished by engaging diverse stakeholders,
by partnering with OHSU investigators, community coalitions, and business enterprises, and by fostering team
science. Through these efforts, OCTRI will become even more essential for OHSU, for Oregon, and for the
nation.

Public health relevance
Project Narrative The Oregon Clinical and Translational Research Institute builds a diverse workforce of researchers who are committed to improving the health of people in Oregon and beyond. It reduces obstacles that slow the translation of ideas into impact. It builds relationships with communities to ensure that research is relevant and useful.